Recent Thymic Emigrants of the CD4 T-cell Lineage

Antigenically-na[unreadable]ve CD4 T cells expressing [unreadable][unreadable]-T cell receptors (TCRs) are critical for generating immune responses to neoantigens, and are produced de novo within the thymus as mature CD4+CD8- thymocytes. These cells enter the periphery to become recent thymic emigrants (RTEs) of the na[unreadable]ve CD4 T-cell compartment. Although monitoring of CD4 RTEs is of great clinical interest, e.g., in cases of CD4 T-cell lymphopenia, direct evaluation of human CD4 RTEs has been limited by a lack of specific surface markers. Heretofore, CD4 RTE production has been indirectly and incompletely inferred by evaluating T cells for their content of signal joint T- cell receptor excision circles (sjTRECs) generated intrathymically. This project will utilize a novel and recently identified surface marker for human CD4 RTEs, protein tyrosine kinase 7 (PTK7), to define CD4 RTE frequency, phenotype, and function. Preliminary results validate PTK7 as a CD4 RTE marker, and show that PTK7+ CD4 RTEs have a reduced capacity for effector function compared to PTK7- na[unreadable]ve CD4 T cells. Aim 1 will use gene expression profiling of unstimulated and stimulated PTK7+ CD4 RTEs and other CD4 T-lineage cells to: 1) define the extent of residual thymocyte gene expression in PTK7+ CD4 RTEs during ontogeny, and 2) identify genes responsible for reduced CD4 RTE immune function. This approach may also reveal new CD4 RTE markers. Aim 2 will use in vivo labeling to determine the lifespan of PTK7+ CD4 RTEs and their conversion into mature PTK7- na[unreadable]ve CD4 T cells, and will determine the role of PTK7+ CD4 RTEs in maintaining na[unreadable]ve CD4 T-cell numbers, sjTREC content, and [unreadable][unreadable]- TCR repertoire diversity in HIV-1 infection. Aim 3 will use a similar approach to test the importance of PTK7+ CD4 RTEs in the reconstitution of na[unreadable]ve CD4 T cells following allogeneic hematopoietic stem cell transplantation. Aim 4 will define the kinetics of loss of PTK7+ CD4 RTEs in children and adults following complete thymectomy, and will determine how this loss impacts na[unreadable]ve CD4 T-cell number, sjTREC content, and [unreadable][unreadable]-TCR repertoire diversity. Together, these studies will substantially enhance our understanding of the role of thymic RTE production in maintaining the peripheral na[unreadable]ve CD4 T-cell compartment in health and disease.

Public health relevance
The production of new CD4 T cells by the thymus is important for the immune system to respond to new infections and vaccines. This research will evaluate the function of the thymus in producing new CD4 T cells, called CD4 recent thymic emigrants (RTEs), including in patients with diseases or treatments that may alter RTE production. This will help to identify patients who could benefit from agents that increase RTE production.